In vivo Reporters of Mycobacterium tuberculosis ESX-5 Secretion

PROJECT SUMMARY/ABSTRACT
Mycobacterium tuberculosis (Mtb) requires the specialized Type VII protein secretion system ESX-5 for growth
in vitro, but little is known about the expression or activity of ESX-5 during infection. A recent report suggested
ESX-5 genes are transcriptionally induced at the acute stage of infection in mice. However, the regulatory
networks and host signals that stimulate ESX-5 expression as well as the stage(s) of infection at which ESX-5
is induced remain to be comprehensively identified. The overall objective of this proposal is to characterize
how Mtb regulates ESX-5 secretion during infection. The proposed research will test the central hypothesis
that ESX-5 is activated in response to specific nutritional cues or environmental stressors to counteract growth
restriction in host interstitial macrophages. Prior studies implicated phosphate limitation as one signal that
induces ESX-5 activity in vitro, but disrupting phosphate-dependent ESX-5 regulation did not impact Mtb
growth or persistence in mice, suggesting that other uncharacterized regulators control ESX-5 in the host.
Preliminary data show that over-expression of two different transcriptional regulators can induce ESX-5
secretion in vitro. Specific Aim 1 will test the hypothesis that specific transcription factors activate ESX-5 in
response to nutritional cues and stress conditions that Mtb encounters in host macrophages. In Specific Aim 2,
fluorescent ESX-5 transcriptional reporters will be developed and tested in macrophage and mouse infection
models using flow cytometry to determine when and in what cell types ESX-5 expression is induced during
infection. Fluorescent reporters of ESX-5 substrate export will also be developed for analysis of ESX-5 activity
during macrophage infection. The innovative fluorescent reporters developed will enable future screens for
small molecules that disrupt ESX-5 expression and/or activity. The proposed research is significant because it
will fill important gaps in knowledge of ESX-5 function by identifying the host cues and regulatory factors that
control ESX-5 expression and establishing the stage(s) of infection when Mtb will be most vulnerable to drugs
targeting ESX-5 or its regulation.

Public health relevance
PROJECT NARRATIVE Mycobacterium tuberculosis (Mtb) induces expression of ESX-5, the only essential ESX (Type VII) specialized protein secretion system, during infection. This proposal seeks to determine how ESX-5 activity is regulated during infection and to develop fluorescent reporters of ESX-5 gene expression and substrate protein export. This fundamental knowledge of the Mtb host-pathogen interaction is relevant to the mission of the NIH because it will facilitate development of new antimicrobials targeting ESX-5 expression or activity to reduce tuberculosis disease burden.